Improving Access to Care and Chronic Condition Management for Rural Older Adults in the US

PROJECT SUMMARY/ABSTRACT
Candidate: Paula Chatterjee, MD MPH is an early stage health services researcher and general internist
interested in improving access to care for rural older adults and narrowing rural-urban health disparities. She
aims to develop content expertise in aging; expand her mixed method research skills; and transition into an
independent investigator dedicated to improving the health of older adults and narrowing health disparities.
Research Context: Older adults make up a growing portion of rural communities in the United States (US),
but have more chronic conditions and limited access to care compared to their urban counterparts. Rural
hospitals, which increasingly provide essential inpatient and outpatient care for older adults, struggle financially
and are at accelerating risk of closure. Global budgets for rural hospitals have been proposed as a strategy to
financially bolster rural hospitals to stave off risks of closure, while transforming rural care delivery to optimally
manage chronic conditions and narrow rural-urban health disparities. Understanding how global budgets might
achieve these outcomes is critically important to understanding how to strengthen rural health care systems.
Specific Aims: (1) Describe trends in access to care, chronic condition management, and corresponding rural-
urban disparities among older adults in the US; (2) estimate changes in access to care, chronic condition
management, and rural-urban disparities among older adults after the introduction of global budgets for rural
hospitals; and (3) qualitatively
chronic
identify hospital-based facilitators and barriers to preserving access, improving
condition management, and narrowing disparities for rural older adults.
Research Plan: Using the Health and Retirement Study and Medicare claims, Dr. Chatterjee will first describe
trends in access to care and chronic condition management, and then use a synthetic control approach to
evaluate the association between the introduction of global budgets in rural Pennsylvania hospitals and these
outcomes. Dr. Chatterjee will then collect primary data from rural Pennsylvania hospital executives to better
understand their efforts to preserve access, improve chronic condition management, and narrow disparities.
Career Development Plan: Dr. Chatterjee will (1) develop content expertise in aging and health care delivery
for older adults, particularly those in rural communities; (2) broaden and solidify research skills in causal
inference, qualitative methods and implementation science; and (3) execute a research agenda focused on
improving the health of older adults with chronic conditions. She will achieve these goals under a team of
leading experts in aging, rural health, health disparities, econometrics, and qualitative methods.
Environment: The University of Pennsylvania is an ideal environment to achieve these training aims under the
guidance of an experienced and multidisciplinary team of Mentors and Advisors with a strong track record in
developing independent health services researchers in aging and health services research.

Public health relevance
PROJECT NARRATIVE Older adults make up a growing portion of rural communities in the United States, but are experiencing a two- pronged challenge of an increasingly severe burden of chronic conditions and limited access to health care— both of which have the potential to exacerbate existing rural-urban health disparities. The goal of this proposal is to measure trends in access to care, chronic condition management, and rural-urban disparities in these outcomes among older adults in the United States, and measure the effects of a novel strategy designed to bolster rural health care delivery, known as global budgets, on these outcomes using a mixed methods approach.